DIAGNOSIS IN CHILD PSYCHIATRY

To investigate the basis for widely disparate rates in the diagnosis of childhood hyperactivity between the U.S. and U.K., research teams and clinician panels in both countries rated a set of 36 standardized case histories, using both ICD-9 and DSM-III diagnostic schemes. Half of the cases had brief videotaped interviews. The rates for diagnosis of hyperactivity were affected by the diagnostic scheme, being considerably lower with ICD-9, which permits only one Axis I diagnosis. This effect was principally for British raters. With DSM-III, the rates were similar for British and American raters. Inter-rater agreement was acceptably high only for specially trained research teams: Within panels of experienced diagnosticians there was much disagreement. The presence of a videotape of part of the psychiatric interview did not affect inter-rater agreement.